Understanding the genetic and immunologic basis of autoimmune hemolytic anemia (AIHA) in a novel canine model system

Project Summary/Abstract
Autoimmune hemolytic anemia (AIHA) is a severe hematologic disorder caused by the antibody-mediated
destruction of red blood cells (RBCs). The disease causes significant morbidity and mortality for patients: With
today's treatments, patients face a significant risk of death, high relapse rates, and only a rare chance at full
remission. Better therapies are possible, but our limited understanding of the genetic and immunologic
mechanisms that lead to AIHA are roadblocks to making new treatments a reality. Fortunately, dogs provide an
exceptional naturally occurring model for studying genetic risk factors and T cell biology in AIHA. The disease
is naturally occurring in both humans and dogs, and shares similar clinical, genetic, and immunologic
underpinnings in both species – while occurring significantly more frequently in dogs compared to humans.
The goal of this study is to lay the groundwork for a canine model system to study AIHA by identifying genetic
risk factors for the disease and by characterizing the autoreactive T cell population in two highly predisposed
dog breeds. Specifically, we will test the hypothesis that we will identify multiple genetic risk variants affecting
humoral immunity, along with autoreactive CD4+ T cells that are activated by peptides derived from RBC
surface antigens. Once we identify genetically predisposed dogs and the T cell epitopes that trigger AIHA, we
can begin to develop and test approaches that manipulate or downregulate the aberrant immune response in
highly predisposed animals. Ultimately, we expect to use this canine model system to drive advances in our
understanding of AIHA and foster the development of novel immunotherapies for humans. The work proposed
in this application will be completed by a highly collaborative team of scientists anchored at the renowned
Center for Immunology at the University of Minnesota Medical School, the University Minnesota College of
Veterinary Medicine, and the University of Georgia College of Veterinary Medicine.

Public health relevance
Project Narrative Autoimmune hemolytic anemia (AIHA) is a life-threatening but understudied blood disorder caused by the immune-mediated destruction of red blood cells. The goal of this proposal is to investigate the genetic and immunologic underpinnings of AIHA in the dog, where the disease occurs naturally at a high frequency in several breeds and shares nearly all the same clinical features with humans. Our hope is that by understanding AIHA in the dog, we can lay the groundwork for an animal model system to help develop next-generation immunotherapies for humans in the future.